Dietary restriction and associated changes in gut microbiota to prevent Alzheimer disease

PROJECT SUMMARY/ABSTRACT Our hypothesis is that overnutrition coupled with impaired dietary amino acid turnover may play a role in Alzheimer disease (AD) pathogenesis. goals are to manage amyloid and tangle homeostasis by nutrition to prevent and treat AD. Restriction of protein, Leu, Met, branched-chain amino acids (BCAA) can improve longevity in rodents without calorie restriction. Failure of Met or BCAA degradation are caused by inherited diseases -- homocystinuria and maple syrup urine disease -- that are fatal when untreated and cause mental retardation. Treatments include restricting Met or BCAA or Leu. Therefore, our hypothesis is that MR and BCAA- R can help in managing and preventing AD by limiting metabolic load and epigenetic changes. The primary purpose of this study is to treat amyloidosis and tauopathy in an AD mouse model by restricting Met levels and to compare the treatments with other dietary restriction (DR) approaches. We propose that by restricting Met and other nutrients, the reduced metabolic load will lead to a fasting condition and reduce amyloid β (Aβ) protein precursor (APP) levels due to its rapid turnover (20 min half-life). The studies will use behavior as an endpoint to measure overall health of the mice. Although behavior is a complex change that may not linearly correlate with degeneration and pathology, it provides a go/no go decision for mental health improvement. We will use tissues from control and restricted mice to follow AD-like neuropathology and neuronal integrity to test the hypothesis that the interventions can prevent AD and related dementias. Most studies on AD have focused on Aβ and senile plaques. A salient feature of the current study is that we will determine the effects of DR on Aβ, Microtubule-associated protein Tau (MAPT) and a combination of both lesions in littermates. Finally, it has recently been recognized that the number of microbes rival human cells particularly in the alimentary canal. Moreover, studies have shown that the gut microbiota can affect nutrition, and vice versa, in both positive and negative ways and impact immune, metabolic and neurological functions. Hence, it is important to understand the associations between gut microbiota composition, dietary modification and disease outcome to realize the contribution of gut microbes to dietary intervention of AD associated neuropathology. We will therefore examine the gut microbiome in all the treatments. Since a 1.5 x increase in APP can induce FAD, the small reduction over time in its expression should prevent or delay AD. Dietary restriction and exercise may provide useful paradigms that may be readily implemented for prevention of AD.

Public health relevance
Project Narrative Alzheimer's disease (AD) is the most common cause of dementia and is currently untreatable and unpreventable despite the major advances in understanding the basis of its neuropathology. Dietary interventions aimed at blocking the nutritional excesses of civilized societies may help prevent or slow the disease and also provide additional tools for understanding the basis of the disease for future targeted interventions.